Environmental exposure modulation of the ovarian lipidome

ABSTRACT
Infertility affects over 50 million couples worldwide and it is associated with both, obesity and dyslipidemia.
Lipids account for ~50% of all cell membranes, ~40% of cells, and play a key role in ovarian function. Despite
its abundance, our understanding of the ovarian lipidome, including abundance, distribution, and function
within specific ovarian regions, remains at its infancy. This hampers our ability to determine how ovarian
dyslipidemia can result in infertility. Advancement in this field has been severely curtailed by: 1) loss of lipids
when using common tissue preservation methods, 2) difficulty in lipid annotation, 3) lack of available human
ovarian lipidome databases, and 4) difficulty to study lipids while retaining a spatial context. Using state-of-the-
art Matrix-Assisted Laser Desorption Ionization Time of Flight Mass Spectrometry Imaging (MALDI-TOF MSI)
we are now capable of retaining the spatiality required to study the ovarian lipidome. This approach greatly
enhances our ability to identify disruptions in the ovarian lipidome induced by chemical exposures, which is the
goal of this proposal. Chemical exposures can induce dyslipidemia in adipose and non-adipose tissues, such
as the ovary. One of such chemicals are organophosphate flame retardants (OPFRs), emerging chemicals that
are increasingly prevalent human urine and plasma. We and others have demonstrated that OPFRs exposure
leads to ovary and ovarian cells’ dyslipidemia, ovarian dysfunction, and poor reproductive outcomes. We
hypothesize that OPFR-induced ovarian dyslipidemia is region- and lipid-specific. To address this, we will first
develop a spatial ovarian lipidome map of the human and mouse ovary coupling untargeted lipidomics with
mass spectrometry and MALDI-TOF MSI. We have demonstrated how this approach can robustly evaluate
lipid distribution and abundance within ovarian regions (germ cells, follicles, cortex, and stroma) with superb
specificity in both human and mouse ovaries. Capitalizing on this platform, we will next evaluate the impact of
environmentally relevant OPFRs exposures on ovarian lipids at environmentally relevant exposures in a mouse
model. Altogether, this will provide the first ovarian lipidome map of chemically-sensitive cellular ovarian
regions for OPFRs. These results will help infer sensitive ovarian targets of OPFRs disruption. We expect that
the results from these studies will provide a platform for discovering new predictors of ovarian dysfunction.

Public health relevance
NARRATIVE Chemical exposures can lead to ovarian dysfunction and infertility with recent studies suggesting that they can result in dyslipidemia in non-adipose tissues such as the ovary. Yet, our inadequate knowledge of the ovarian lipidome limits our ability to understand if ovarian dyslipidemia is one of the contributors of female infertility. Understanding the mechanisms of chemically-induced ovarian dyslipidemia, is the first step before preventive or palliative strategies can be developed, and quality of life of women with infertility could be greatly enhanced.